The Role of Exogenous Type VII Collagen on the Healing of Skin Wounds

We have made the surprising finding that type VII (anchoring fibril) collagen (C7) exogenously administered
to murine skin wounds, both topically and intravenously, induces dramatic acceleration of wound closure and
the wounds heal with less scarring. This was an unexpected finding because, under normal conditions in
unwounded skin, C7 is configured into large structures called anchoring fibrils which are confined to the
junction between the dermis and epidermis, the dermal-epidermal junction (DEJ). For many years, we have
studied the structure and function of C7 and were surprised to find that in the wound bed of healing skin
wounds, C7 is not confined to the DEJ, but, rather, is widely distributed throughout the wound bed. We also
developed procedures for making milligram quantities of recombinant human type VII collagen (rhC7). We
added rhC7 to 1 x 1 cm standard full-thickness wounds on the backs of hairless mice and evaluated wound
closure. We found that compared with vehicle control or no treatment, rhC7-treated wounds exhibited
dramatic acceleration of wound closure. The same results also occurred when we treated skin wounds made
in diabetic mice who exhibit delayed skin wound healing. We also transplanted human skin onto the backs of
athymic mice, wounded the transplanted human skin and applied either vehicle or rhC7. Again, rhC7 induced
accelerated wound closure in the human skin compared with the vehicle. rhC7 had specific activity since
other large macromolecules (type I collagen, type IV collagen, fibronectin, and laminin 332) did not accelerate
wound closure in these animals. It was also noted that the murine skin wounds treated with rhC7 healed with
less clinical scarring. We then evaluated vehicle- and rhC7-treated murine wounds by histology and by
immunohistochemistry for markers of scarring. Compared with vehicle-treated wounds, murine skin wounds
treated with rhC7 exhibited a dramatic down-regulation of markers of scarring including collagen deposition,
smooth muscle actin positive fibroblasts (myofibroblasts), connective tissue growth factor, periostin and pro-
fibrotic isoforms of transforming growth factor beta (TGFb). Given these unexpected dramatic results, the
subject of this grant is the role of C7 in the healing of skin wounds. Recently, we have also established
the first and only diabetic pig with delayed healing of skin wounds. In this proposal, we wish to determine the
influence of topically administered rhC7 on skin wounds made in domestic pigs, both normal and diabetic.
Performing experiments with pigs is critical because pigskin is much more relevant to human skin. Pigs are
tight-skinned animals and have skin the most similar to human skin. Pigs are the species of choice for wound
healing studies. We will also determine if topical rhC7 inhibits scarring and generates elements of
“regenerative” healing rather than just “reparative” healing. We will also establish the stability of rhC7 in
pigskin wounds as a surrogate for healing human wounds. This will be important for determining the dose
and dosing schedule of rhC7 as a new wound healing agent for humans with chronic skin wounds. Once the
optimal dose and dosing schedule of topical rhC7 is established, we will determine if rhC7 accelerates wound
closure and inhibits scarring in diabetic pigs. Wound healing is an enormous clinical problem, especially for
military personnel and Veterans. Veterans often suffer predisposing conditions for chronic skin wounds such
as diabetic ulcers, stasis dermatitis leg ulcers and decubitus ulcers from immobility due to spinal cord injuries.
The problem is escalating due to rises in obesity and diabetes. We will evaluate for the first-time wound
healing mechanisms in normal skin versus diabetic skin in the animal most relevant to humans. We have
these exciting observations regarding skin wound responses to rhC7, but we do not know the
pathophysiological mechanisms behind them. The planned experiments will inform us of the basic
mechanisms underpinning these observations. They will also advance bringing rhC7 from the research
laboratory to the clinic for patients, so-called “bench-to-bedside” research.
!
!

Public health relevance
Skin wounds are a major problem for both our US military personnel and our Veterans, many of whom suffer burn injuries, spinal cord injuries with decubitus pressure ulcers, leg edema with stasis ulcers, and diabetes complicated by diabetic lower limb ulcers. There is only one FDA-approved biologic for accelerating skin wound healing, and it has modest efficacy, limited indications, significant expense, and carcinogenic potential. For years, we have studied type VII collagen (C7) and have recently discovered that human recombinant C7 (rhC7), when added exogenously to skin wounds made in mice, dramatically accelerates wound closure and inhibits scarring. We will study if topical rhC7 accelerates wound closure and inhibits scarring in normal and diabetic pigs (the species of choice and the closest wound healing model for human skin). The results of this study will bring rhC7 from the laboratory to the bedside, particularly benefitting millions of Veterans with chronic skin wounds.